PREDICT-FTD: Multimodal Imaging Prediction of FTLD Subtypes.

Project Summary
Frontotemporal lobar degeneration (FTLD) is a devastating neurodegenerative disorder, and a common
cause of dementia in people under the age of 65. Recent advances are offering hope for disease modifying
interventions, but such treatments will only be effective if patients are accurately diagnosed, and likely to be
most effective early in the course of disease. The ability to accurately predict the type of clinical syndrome is
critical for selecting appropriate early interventions that may be targeted for specific symptoms at specific
stages. The ability to accurately predict the age at which the symptoms will emerge is critical for clinical trials,
which requires accurate measures that can indicate that the individual at risk is likely to develop symptoms
within a specific timeframe. Unfortunately, the type of clinical syndrome and age of onset can vary dramatically
even within the same mutation. An individual with a given mutation can eventually develop any of the FTLD
syndrome subtypes, and the age of onset of clinical syndromes can also vary within the same mutation. This
striking clinical heterogeneity in FTLD due to genetic mutation severely limits our ability to predict when and
what specific symptoms will emerge. Neuroimaging studies of symptomatic and presymptomatic FTLD
mutation carriers have shown detectable gray matter and white matter changes across all mutations. However,
the variability in the clinical syndrome trajectories that exist in each mutation has led to mixed findings. A small
number of studies of presymptomatic mutation carriers who went on to develop clinical symptoms suggest that
presymptomatic structural changes can be used to predict time to dementia. However, their sample sizes were
small, often are numbered in the single digits or low teens, thus leaving many unanswered questions, including
whether prediction differs by mutation and whether specific syndromes can be predicted, and whether the
choice of neuroimaging measures may depend on the stage of the presymptomatic progression. Our proposed
study will use large-scale longitudinal multimodal neuroimaging datasets of presymptomatic FTLD mutation
carriers to predict the type of syndrome that they will develop and the time of onset. 1) We will focus on the
presymptomatic trajectory of eventual clinical syndromes and develop new models that incorporate longitudinal
data. 2) We will leverage the largest international consortia studies that follow presymptomatic mutation
carriers. 3) We will consider more sensitive imaging measures. 4) Finally, we will employ powerful machine-
learning-based methods appropriate for our proposed sample size. If successful, the methods and measures
we develop can inform clinical trials that require accurate predictors of timeframe before conversion. If and
when effective treatments become available, reliable predictors of when and which syndrome an individual will
develop can be used for selecting appropriate early interventions that may be targeted for specific symptoms at
specific stages, as well as specific measures that should be monitored in each at-risk individual.

Public health relevance
NARRATIVE Frontotemporal lobar degeneration (FTLD) is a devastating neurodegenerative disorder currently without a cure. The ability to accurately predict the type of clinical syndrome and the age at which the symptoms will emerge is critical for clinical trials or for selecting appropriate early interventions. Our proposed study will leverage the largest longitudinal multimodal neuroimaging datasets on presymptomatic FTLD mutation carriers to develop reliable predictors of the type of syndrome that they will develop and the time of onset.